A Novel Therapy For Preeclampsia

Preeclampsia remains a major health concern, affecting 5-10% of all pregnancies in the United States. It is a leading cause of maternal and perinatal morbidity and mortality. Currently, there is no effective therapy for the management of the preeclamptic patient, with the disease only remitting after birth. While the underlying mechanisms are not clear, it is believed that inadequate remodeling of the maternal vasculature leads to placental hypo-perfusion, resulting in chronic placental hypoxia/ischemia. In response the placenta releases pathogenic factors into the maternal blood stream, leading to widespread maternal endothelial dysfunction and hypertension. In recent years, a great deal of attention has been focused on the secretion of an anti- angiogenic protein, the fms-like tyrosine kinase-1 (sFlt-1). Despite intensive research into this pathogenic pathway, no therapeutics have emerged which can adequately target sFlt-1 in the preeclampsia patient. In this proposal, we describe a novel therapeutic protein which consists of placental growth factor (PlGF), a VEGF family member specific for Flt-1, fused to the synthetic protein carrier Elastin Like Polypeptide (ELP), which we have recently demonstrated restricts attached therapeutics to the maternal compartment improving fetal safety during administration. We hypothesize that ELP-PlGF will attenuate the maternal and fetal complications associated with placental insufficiency, and may therefore be a potential therapeutic for the management of preeclampsia. This proposal will study the safety and efficacy of this therapeutic in a relevant preclinical animal model of preeclampsia.

Public health relevance
Narrative. Preeclampsia is a hypertensive disorder of pregnancy that is a leading cause of morbidity and mortality in both the mother and infant, and there is currently no cure other than delivery of the fetus and the placenta. This proposal will test a protein-based drug carrier for delivery of novel peptide based antagonist for sFlt-1, which could have major therapeutic benefit for preeclampsia patients.